Center for Quantitative Biology: A focus on "omics", from organisms to single cells Supplement 1

The human gastrointestinal tract harbors a diverse and dense population of microbes termed
the gut microbiota. This microbial population produces diverse metabolites that collectively
influence human physiology. Two prominent classes of gut microbiota-dependent metabolites
are the bioactive byproducts of tryptophan metabolism and bile acid metabolism. The
complexity of the microbiota, its variation across individuals, and the diversity of tryptophan and
bile acid metabolites produced has resulted in a knowledge gap surrounding the relationship
between metabolite flux and host gene expression. Addressing this knowledge is challenging
due to the breadth and depth of technical expertise required and, to surmount this, we have
assembled an interdisciplinary team. Here, we propose a team research project that leverages
multi-omic data generation from mice colonized with either a complex or defined microbiota in
comparison with germfree mice lacking microbiota. We will develop and employ sophisticated
new multi-dimensional data analysis methods to reveal the impact of microbiota-dependent
metabolite flux on host gene expression. In projects 1 and 2, PIs Sundrud and Ross will
generate quantitative metabolomic profiling data of diverse tryptophan and bile acid metabolites
from conventionally colonized mice and gnotobiotic mice colonized with a defined microbiota
consisting of 14 human-gut-derived isolates capable of producing diverse metabolites.
Metagenomic and transcriptomic datasets including bulk and single-cell RNA sequencing will be
generated from multiple tissues in each group, with a specific emphasis on analysis of intestinal
immune cell populations. In projects 3 and 4, PIs Song and Hoen will develop and implement
new methodologies for integrating these multi-omic data into models which map the
relationships between metabolite abundances and host gene expression. Together, these
projects represent new areas of collaborative research for the team and will establish
comprehensive datasets and models for future collaborative grant applications.

Public health relevance
PROJECT NARRATIVE We propose to use a novel multi-omic approach to investigate the impact of key microbiota-derived metabolites on host gene expression, leveraging our diverse expertise. We will employ sophisticated sampling modalities in conventionally-colonized, germfree, and gnotobiotic mice colonized with a defined synthetic microbiota to generate complex metabolomic, metagenomic, and transcriptomic datasets. We will then develop new biostatistical methods to integrate these datasets in order to reveal how key metabolites, including those derived from microbial metabolism of bile acids and tryptophan, orchestrate transcriptomic and immunologic responses in host tissues like the intestinal lamina propria. Together, this project will provide comprehensive datasets and new models which will facilitate a greater understanding of host-microbe-metabolite interactions in the gut.